Development of clinically translatable MRI methodologies for the thoracic spinal cord

PROJECT SUMMARY
Magnetic resonance imaging (MRI) is critical to diagnosing pathology of the human spinal cord for a wide
array of diseases, conditions, and trauma. The thoracic region of the spinal cord, corresponding to vertebral
levels T1-T12, is frequently involved in conditions such as cord ischemia, dural arteriovenous fistulas, and
hemangioblastoma as well as inflammatory diseases such as multiple sclerosis (MS). There is a clear need for
high quality, nondegraded MRI of the thoracic cord to support diagnosis and treatment planning in the clinical
setting as well as to provide comprehensive evaluation of the spinal cord in translational research studies.
Unfortunately, MRI methods development for this anatomy significantly lags that for the brain and cervical
spinal cord. The thoracic spinal cord is especially challenging to image because, in addition to small size,
physiological motion, and low intra-cord tissue contrast between gray and white matter, this region is directly
adjacent to the lungs and diaphragm and suffers the most from respiration artifacts relative to the cervical and
lumbar regions. Respiration artifacts are caused by the physical motion of the lungs and diaphragm as well as
the temporally varying B0 field homogeneity. Conventional, clinical MRI techniques for the thoracic spinal cord
are often degraded by these artifacts which can necessitate re-acquisition (lengthening scan duration) or
canceling studies, which can negatively impact clinical management. The overarching goal of this project is to
systematically optimize anatomical and diffusion MRI sequences for the thoracic spinal cord that employ
clinically translatable techniques to mitigate these technical hurdles with specific attention to motion and
respiration artifacts. This goal will be addressed in two aims: Aim 1) Optimize clinically relevant anatomical
MRI sequences for the thoracic spinal cord at 3T and Aim 2) Optimize diffusion MRI sequences for the
thoracic spinal cord at 3T. Completion of these aims will provide a clinically feasible protocol for improved
anatomical and diffusion MRI that addresses an important gap in current spinal cord MRI coverage.
Furthermore, this study will generate preliminary data and set the stage for future translational research studies
that will implement comprehensive spinal cord imaging to improve our understanding of spinal cord pathologies
in patient populations.

Public health relevance
PROJECT NARRATIVE Imaging the thoracic spinal cord with magnetic resonance imaging (MRI) is critical to the diagnosis and treatment of a wide array of pathologies including cord compression, ischemia, and tumors. This anatomical structure is especially challenging to image due to its small size, its proximity to the heart and lungs (causing cardiac and respiratory motion artifacts), and the effects of air-bone and bone-fluid interfaces on magnetic susceptibility (leading to field inhomogeneity artifacts) and thus is significantly underexplored. The overall goals of this research are to optimize and implement anatomical and diffusion-weighted MRI methods for the thoracic spinal cord at 3 Tesla field strength that mitigate the impact of those artifacts and can be used in clinical practice.